FlexLock - A novel anchoring guide catheter to simplify transradial complex percutaneous coronary interventions

Abstract
Cardiovascular diseases persist as a significant public health concern, with a five-year survival rate of
approximately 50% and imposing healthcare costs estimated at $250 billion. In the United States, nearly
805,000 individuals experience a heart attack annually, predominantly resulting from coronary artery
disease (CAD). While traditional percutaneous coronary intervention (PCI) techniques have exhibited
substantial effectiveness in managing superficial lesions, 38% of PCI procedures are categorized as
complex, including complex lesions or chronic total occlusions (CTOs). These intricate procedures often
involve numerous challenges, such as complexities associated with coronary anatomy, comorbidities,
concurrent cardiac conditions, and left ventricular dysfunction. The utilization of a stable guide catheter is
essential for the successful execution of these interventions; nonetheless, despite the availability of various
devices in the marketplace, none have effectively provided the requisite backup force for transradial
access, which necessitates a high backup force within a smaller catheter profile. Nimble Surgical aims to
introduce an innovative, manually operable FlexLock guide catheter featuring an anchoring tip that will
deliver simultaneous active and passive support, ensuring stable coronary access without compromising
lumen space and concurrently enhancing perfusion, thereby mitigating the risk of ischemia.

Public health relevance
Narrative Adequate backup force and catheter stability during transradial complex PCI are necessary to treat coronary artery disease. Current devices often sacrifice lumen space to achieve stability, leading to poor procedural outcomes, increased procedure time, and risk of complications. Nimble Surgical’s FlexLock catheter with concurrent active and passive support provides higher backup force and perfusion in a smaller profile, increasing device delivery efficiency and simplifying heart procedures.